RNA Sequencing if Esophageal Tissues During Food Elimination and Reintroduction Reveals Novel Findings Regarding the Early Pathogenesis of EoE

PROJECT ABSTRACT
Eosinophilic Esophagitis (EoE) is a morbid, highly inflammatory condition of the esophagus, increasingly
diagnosed in both children and adults, resulting in substantial healthcare burden for patients and payors. Due to
the need for invasive upper endoscopies for diagnosis, the disease is not identified for years after the onset of
symptoms. Yet, identifying and controlling the disease early in its development would provide a means to
personalize therapy and reduce complications. Our long-term goal is to detect and characterize the early
epithelial signals which precede the development of persistent, chronic EoE, identifying biomarkers of early
disease, in order to reduce the burden of this morbid, inflammatory process. The overall objective for this
application is to characterize the molecular pathways responsible for disease initiation, differentiating them from
those that are responsible for the maintenance and persistence of inflammation over years. Our central
hypothesis is that the initiation of EoE involves specific reversible (preventable) epithelial signals which
propagate and perpetuate a robust, complex, inflammatory reaction leading to diffuse esophageal inflammation,
fibrosis, narrowing, and life-altering symptoms of choking, food impactions, and food/social aversion. Our
rationale stems from our discovery that specific pathways are differentially regulated within esophageal tissues
during food elimination/reintroduction diets. The central hypothesis will be tested by pursuing two specific aims:
(1) to differentiate RNA signatures responsible for the initiation of EoE (acute EoE) from those involved in
persistent, longstanding inflammation (chronic EoE);and (2) to identify the specific epithelial and immune
pathways which precede the onset of robust, diffuse esophageal eosinophilia. Under the Aim 1, the RNA
signatures from paired biopsies taken prior to food elimination (“chronic” EoE) and after recurrence of EoE during
reintroduction of trigger foods (“acute” disease phase) within patients will be compared to differentiate the
processes involved in disease initiation and disease persistence. For the Aim 2, tissues from patients who
resolved their EoE with food elimination diet and subsequently demonstrated “patchy” recurrence of disease
upon trigger food reintroduction (i.e. obvious eosinophilic inflammation and endoscopic signs of EoE interspersed
with normal-appearing tissue) will undergo spatial transcriptome sequencing to localize and decipher the cellular
contributions involved in disease recurrence. The proposed research is innovative in its study of human samples
to thoroughly categorize early changes involved in disease initiation. This study of early transcriptional signals
capitalizes on biopsies performed during food elimination/reintroduction diets which remove and then expose
patients to the antigenic stimulus – essentially recreating a scenario which mimics disease genesis.
The significance of the research lies in the identification of new biomarkers and eventual interventions/therapies
for early stages of EoE. Collectively, our observations should inform future investigation into early markers of
disease and the development of pre-emptive therapies to prevent disease progression.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health by identifying the initial epithelial pathways that lead to the initial onset and persistence of EoE. Identifying the spectrum of changes integral to the original development leading to the continuation and progression of Eosinophilic Esophagitis (EoE) will lead to new and improved biomarkers of disease and ultimately contribute to novel therapeutic approaches. The proposed research is relevant to NIH’s mission for a precision medicine approach that will improve health and quality of life for patients suffering from EoE.